The Circuit Logic of Modulation of Locomotion by Odors

PROJECT SUMMARY
There is a fundamental gap in our understanding of the circuit mechanisms underlying even simple naturalistic
behaviors, such as making a cup of coffee, which proceed through a sequential execution of sub-behaviors. The
continued existence of this gap represents an important problem because obtaining a circuit-level understanding
of complex multi-step behaviors is a necessary step toward unlocking the mysteries of healthy brain function and
disorders. The overarching goal is to obtain a circuit-level understanding of such naturalistic behavior. The
research objective here is to unravel the logic of sensorimotor transformation in the context of odor modulation of
locomotion in Drosophila. Our group has pioneered methods to quantitatively assess how odors affect a fly's
locomotion. We have also described the overall transformation between the activity of the olfactory receptor
neurons (ORNs) and the resulting change in locomotion and found that this transformation is well-described by a
mapping between the activity in the ORN and changes in locomotor parameters. This mapping is distinct for
different locomotor parameters and suggests that there are parallel sensorimotor modules. The central hypothesis
underlying the research proposed here is that the third-order olfactory neurons in the fly's lateral horn (LH) play
an important role in mediating this transformation. LH receives input from the fly's olfactory system and is
connected to premotor neurons in the fly's brain, and is, therefore, in the correct anatomical location to transform
activity in the olfactory system into changes in locomotion. In particular, we hypothesize that lateral horn output
neurons (LHONs) will mediate the specific transformation between ORN activation and each locomotion
parameter. This hypothesis was formulated based on previous work and preliminary data. The rationale for the
proposed research is that understanding odor-guided locomotion—a complex, flexible behavior—in the context
of a genetically tractable system will allow a precise delineation of the steps that underlie sensorimotor
transformation in the context of naturalistic behavior. The hypothesis above will be tested by characterizing the
circuit basis of modulation of locomotion by food odors using a combination of techniques, including imaging,
electrophysiology, quantitative behavior, and computation. The proposed research has three specific aims. 1) To
investigate the rules of olfactory sensory integration in the context of naturalistic behaviors 2) To investigate the
relationship between activity in LHONs and locomotion. 3) To investigate the contribution of LHONs in different
contexts. The research is innovative because it employs sophisticated statistical tools and cutting-edge
experimental tools in the context of a genetically tractable model organism to obtain insights into naturalistic
behaviors. The proposed research is significant because it will vertically advance our understanding of
sensorimotor processes involved in naturalistic behaviors. Besides representing a vertical advance in our
understanding of naturalistic behavior, another possible positive outcome of this study is a better diagnosis of
neurological conditioning that occurs through improper sequencing of actions.

Public health relevance
Public health: The ability to execute complex behaviors in response to sensory responses is disrupted in many diseases. The research proposed here is aimed at understanding the logic underlying the control of complex behavior and how this control is organized in neural circuits. This understanding will lead to better management of diseases affecting proper execution of behavior.